RgIA5474 as a Novel α9α10 Nicotinic Acetylcholine Receptor Antagonist to Treat Migraine

Project Summary
Treatment of episodic migraine relies on acute therapies that are often not effective in as many as half of the
patients. We wish to test the relevance of α9α10 nicotinic acetylcholine receptors (nAChRs) as a new
target for the treatment of migraine. We hypothesize that RgIA5474, a peripherally restricted, highly
selective α9α10 nAChR antagonist, may be effective in the treatment of migraine-like pain, especially for patients
who don’t respond to CGRP blockers and are contraindicated for triptans. This hypothesis originated from the
realization of strong autonomic nature of symptoms associated with migraine. The α9-expressing nAChR is
highly permeable to Ca2+. When co-expressed with α10 subunit, the α9 subunit current induced by ACh is
increased by about 100-fold. Notably, the expression of α9α10 subunits is highly restricted outside the central
nervous system (CNS), mainly at the adrenal gland medullary chromaffin cells and immune cells, besides the
inner ear hair cells where they were initially discovered. Activation of α9α10 nAChRs promotes the release of
inflammatory mediators from the immune cells and stress hormones from the adrenal medulla. Both could
activate trigeminal neurons and elicit release of neuropeptides like calcitonin gene-related peptide (CGRP) and
pituitary adenylate cyclase-activating polypeptide (PACAP), leading to migraine pain. The release of CGRP and
PACAP could further stimulate the release of inflammatory mediators. Therefore, α9α10 nAChR antagonists may
represent a viable novel mechanism for acute treatment of migraine-related pain. Importantly, the limited
distribution of α9α10 nAChRs may confer a great advantage of limited side effects, especially lack of CNS side
effects. RgIA5474 is a 3rd generation peptide modified from a marine snail toxin that has better plasma stability,
higher affinity (IC50 at pM range) and selectivity for both rodent and human α9α10 nAChRs than the previously
tested analogs including the 2nd generation RgIA4, offering strong translational potential. Our preliminary data
demonstrated that one acute dose of RgIA4 blocked the development of evoked cephalic and extracephalic
allodynia and spontaneous facial grimace induced by inflammatory mediators in mice and reversed the
cutaneous allodynia induced by bright light stress in rats sensitized by sumatriptan. We will evaluate RgIA5474’s
dose- and time-dependent effects in alleviating migraine-related pain in female and male CBA/CaJ mice using 2
non-invasive mouse models induced by human migraine triggers. Two specific aims will evaluate pain related
behavioral (cephalic allodynia and facial grimace score), neurochemical (plasma release of pro-inflammatory
cytokines), as well as immunohistochemical (activation of trigeminal ganglia and trigeminal nucleus caudalis)
changes induced by supradural CGRP or PACAP38 (with CGRP receptor antagonist on board) for CGRP-
dependent and CGRP-independent mechanisms, respectively. α9 knockout mice will be utilized to verify the
contribution of this target to migraine pathology. These studies will help us determine whether blockade of α9α10
nAChRs is a viable strategy for development of a novel therapeutic class for migraine treatment.

Public health relevance
Project Narrative Migraine is extremely debilitating and undertreated due to insufficient efficacy and/or intolerable side effects of the current abortive therapeutics. We will assess α9α10 nicotinic acetylcholine receptors (nAChRs) as a potential new target for treatment of migraine. We will determine the efficacy of RgIA5474, a novel peptidic antagonist highly selective to both human and rodent α9α10 nAChRs, in alleviating evoked and spontaneous pain, enhanced release of inflammatory mediators, as well as activation of trigeminal systems following human migraine triggers in wild type and α9 knockout mice.